Alzheimer's disease and novel nanotherapeutics exclusively targeting extrasynaptic NMDA receptors

PROJECT SUMMARY
Alzheimer’s disease (AD) is a progressive neurodegenerative disorder with a devastating socioeconomic
impact. The failure rate in AD clinical trials is still ~99%, and the goal of finding efficient drugs that can stop
and/or reverse the course of AD remains elusive so far. One of the reasons for these failures is a multifactorial
nature of AD which makes it is very challenging to identify the “right” target for efficient therapeutic intervention.
NMDA receptors (NMDARs) represent one of just two targets that were clinically validated in AD patients.
Therapeutic doses of memantine, an NMDAR antagonist approved by the FDA for treatment of moderate-to-
severe AD, were shown to delay the AD progression for 12 weeks and inhibit disruption of spatial learning
through prevention of glutamatergic excitotoxicity triggered by elevated extracellular tonic glutamate levels
leading to activation of extrasynaptic NMDARs (eNMDARs). However, meta-analysis of the memantine’s effects
shows that memantine produces modest, short-lived, and highly heterogeneous clinical response. Administering
memantine at higher concentrations or during the earlier AD stages is not an option because memantine may
trigger serious psychomimetic side effects associated with the block of normal brain activity mediated by synaptic
NMDARs (sNMDARs). Focusing efforts on drugs that block eNMDARs but not sNMDARs will avoid side effects
associated with NMDAR antagonists, while producing an enhanced disease-modifying neuroprotective therapy.
To address the critical need for exclusive antagonists of eNMDARs, we applied the rational drug design and
engineered a nanotherapeutic (AuM) that is sufficiently large to be excluded from the synaptic cleft, thus, sparing
sNMDARs, but still small enough to efficiently penetrate the brain tissues, reaching and blocking eNMDARs. We
found that exclusive eNMDAR antagonists provide much stronger neuroprotection than memantine in several
models associated with glutamatergic excitotoxicity, including protection of dendritic spines from Aβ oligomers.
Based upon these exciting results, we propose to conduct an extensive evaluation of our exclusive eNMDAR
antagonist AuM in two complementary AD models: 5X-FAD mice, a model of AD-related amyloid deposition, and
P301S tau × ApoE4 homozygous knock-in mice, a tauopathy model. We will compare AuM-treated mice to
vehicle-treated mice for disease-relevant read-outs and outcomes, tailored respectively to each model, including
behavior (memory/learning), accumulation of amyloid plaques or tau tangles, microglial activation/function, CSF
biomarkers, and neuropathology. We also propose to evaluate the feasibility of nose-to-brain delivery of AuM
with the goal of establishing a clinically relevant route for our nanotherapeutic. Specifically, we will determine the
time course of AuM distribution in 5XFAD mice after either direct intra-brain delivery or intranasal administration.
The data acquired during this project will allow us to develop the efficient strategy to pursuit of IND-enabling
studies for exclusive antagonists of eNMDARs for treatment of AD.

Public health relevance
PROJECT NARRATIVE NMDA receptors (NMDARs) are the clinically validated target for Alzheimer’s disease (AD), but memantine, an NMDAR antagonist approved by the FDA for moderate-to-severe AD, is not sufficiently efficacious, partly because memantine only acts as a preferential, rather than exclusive, antagonist of the extrasynaptic NMDARs (eNMDARs) that are linked to the activation of multiple pathological signaling pathways in AD. We recently developed a first-in-class exclusive eNMDAR antagonist, which puts us in a unique position to directly examine the molecular and functional impacts of the activity of eNMDARs on multiple aspects of AD-related pathology. Building on our proof-of-concept studies showing that exclusive eNMDAR antagonists can provide neuroprotection in several disease models associated with glutamatergic excitoxicity, we propose to test our exclusive eNMDAR antagonist in two complementary AD mouse models. Our overarching aim is to develop a novel therapeutic for AD patients with minimized side effects and greatly enhanced therapeutic benefits.